HUMAN EXPOSURE TO HALOGENATED AROMATIC COMPOUNDS

Polychlorinated biphenyls (PCBs) and the DDT family are toxic, widespread hydrocarbons that are poorly understood in terms of their toxicity for human beings. In addition to their direct toxicity, both of these chemicals pass from mother to child through the placenta and by contaminating breast milk. This project includes a study of subjects exposed to low levels of these compounds in the US and a study of subjects exposed to higher doses in Taiwan. The Breast Milk and Formula study is a birth cohort follow up study of 856 North Carolina children. PCBs and DDE (the stored metabolite of DDT) are measured in breast milk and the children are followed medically over time. All children have completed 5 years of observation and are now followed only by a birthday card registry. Higher exposure to PCBs while the children were in utero correlate with lower developmental scores at ages 6 and 12 months: there is no additional effect from exposure through breast milk, and no persistent effect with DDE exposure. An epidemic of 2000 cases of PCB poisoning occurred in Taiwan in 1979. Rice oil was accidentally contaminated during manufacture. We did a survey of 117 children who were born to mothers who were poisoned, 40 of their older siblings, and 107 controls. All children received a physical examination and the mothers answered a questionnaire about their children's health. A few of the children have mild hepatic porphyria, and in general the transplacentally exposed children show a syndrome most consistent with an acquired ectodermal dysplasia.